Developmental Mechanisms Driving Cell Invasion in Pediatric Brain Cancers

PROJECT SUMMARY – HUNTSMAN CANCER INSTITUTE, RODNEY STEWART
Embryonic morphogenesis mechanisms are frequently activated in human cancers, particularly childhood brain
tumors. In particular, genes that regulate neural crest (NC) epithelial-to-mesenchymal transition (EMT) and cell
migration, such as the Snail family of transcription factors, are often re-activated in tumor cells to promote
malignant progression by changing the available repertoire of cell adhesion, cytoskeletal, apoptotic and
signaling molecules. This leads to enhanced tumor-cell dissemination, self-renewal and chemo-resistance, a
devastating combination that promotes treatment failure and cancer-related mortality. The long-term goal of
this research is to define the essential, conserved and rate-limiting effectors of embryonic EMT programs that
drive cancer progression in order to identify new targets and therapeutics that can be used alone or in
conjunction with current therapeutics to eliminate tumor cells. The overall objective of the current project, which
represents the next logical step toward our long-term goal, is to 1) use the powerful genetic attributes of the
zebrafish system to identify new mechanisms driving NC EMT and cell migration and 2) determine if inhibiting
one or more EMT effectors in a model of pediatric brain tumors prevents tumor invasion and/or dissemination.
The central hypothesis is that a subset of cell adhesion, cytoskeleton and/or signaling molecules are essential
for executing NC EMT and that these molecules represent promising targets to inhibit EMT-induced brain
tumor invasion. Guided by published and preliminary data, this hypothesis will be tested by pursuing three
specific aims in which we will: 1) determine if the highly conserved Foxd3 transcription factor directly controls
the expression of Snail genes during EMT, 2) identify essential effectors of Foxd3/Snail-dependent EMT during
NC development and 3) determine if one or more NC effectors are required for brain tumor invasion in vivo.
The proposal is innovative because it employs new genetic and imaging technologies to dynamically measure
and manipulate the impact of developmental EMT programs during brain tumor invasion in whole animals at
single-cell resolution for the first time, allowing the rapid identification of new targets and therapeutics for brain
cancers. The successful completion of the proposed research will have a significant impact because it is
expected to vertically advance and expand our understanding of how to manipulate developmental EMT
programs in a number of disease settings, including NC-derived birth defects, fibrosis and cancer invasion,
thus allowing for the strategic design of effective treatments for these diseases.

Public health relevance
PROJECT NARRATIVE – HUNTSMAN CANCER INSTITUTE, RODNEY STEWART The spread of tumor cells is the primary cause of cancer mortality because of limited treatment options. The proposed research is relevant to public health because it is expected to identify conserved molecular targets that control invasion of neuroepithelial cells in both normal development and invasive pediatric brain tumors. The project is relevant to the missions of the National Institute of Neurological Disorders and Stroke and the National Cancer Institute because it seeks to improve our understanding of the cellular mechanisms underlying cell migration and cancer invasion arising from neural progenitor cells.